Utility of PIP as a Novel Keratoconus Biomarker | Supplement

ABSTRACT (Parent award)
Keratoconus (KC) is the most common corneal dystrophy, with adverse corneal changes that can dramatically
affect vision. During KC progression, the cornea can show several pathologies, including fragmentation of
Bowman’s layer, thinning of stroma and overlying epithelium, folds or breaks in Descemet’s membrane, and
variable amounts of diffuse corneal scarring. Clinically, limited treatment options for KC patients include
corneal transplantation and collagen cross-linking. Unfortunately, both corneal transplantation and collagen
cross-linking have their own limitations. To date, the etiology and pathogenesis of KC remains unclear. As
such, there is an urgent need to identify viable biomarker(s) that can help with the early diagnosis and
treatment of KC. In 2014, we were the first to report the role and significant modulation of prolactin-induced
protein (PIP) in vitro (3D cultures with human KC cells) and in vivo (human tear samples), and question its role
during KC development and progression. Our preliminary data shows that PIP is significantly downregulated in
KC patients when compared to Healthy individuals. Interestingly, downregulation of PIP was seen in three
different human biological fluids: saliva, tears, and blood (serum). Furthermore, our preliminary data shows that
PIP is not modulated in other relevant diseases, such as Uveitis and Type II Diabetes, suggesting potential
specificity to KC. Even more strikingly, new data shows that PIP expression levels returned to normal on KC
patients that had received corneal transplants. We posit that PIP can serve as a biomarker for KC onset
and progression drive the development of future non-invasive treatment modalities. The current
proposal is focused solely on PIP, with three main goals: 1) Cement PIP as a KC biomarker, 2) Determine the
power and specificity of PIP, and 3) Determine PIP expression following known KC treatments. To ensure that
we achieve our goals, we have assembled a large cohort of experts in the field from multiple clinical and
research centers, as well as from the National Keratoconus Foundation (NKCF). Successful completion of the
studies proposed will be a breakthrough in KC research and will alter current standards of care for patients with
KC.
Relevance to Public Health – KC is a major clinical problem resulting in visual impairment worldwide. There is
an urgent need to develop novel diagnostic tools for the detection and treatment of KC in the early stages.
Ultimately, the primary goal is to enable people with KC to live a normal life with little or no visual disability. The
proposed work will move the field forward, is translational, clinically relevant, and in line with NEI’s program
goals: “Apply the knowledge acquired from discoveries in the basic science of the cornea and other tissues of
the ocular surface to the diagnosis, prevention, and treatment of ocular injury and disease”.

Public health relevance
PROJECT NARRATIVE (Parent award) Keratoconus (KC) disease is the degeneration of the corneal stroma, which causes the cornea to slowly change from its’ normal curved shape to a more conical shape, leading to vision distortion. Unfortunately, to- date, the etiology of the disease is unknown, and in most cases, patients require some kind of surgical intervention. We propose to validate the role of Prolactin-Induced Protein as a new KC biomarker using human saliva, tears, and blood samples.